A hyperspectral approach to RPE fluorophores in AMD

Clinical trials for age-related macular degeneration (AMD) depend on imaging outcomes to measure success.
Strong autofluorescence (AF) signal from the retinal pigment epithelium (RPE) has high potential for
noninvasive, spatially and molecularly precise early detection, and longitudinal follow-up. Subcellular signal
sources of RPE AF are lipofuscin (LF) granules, many also containing melanin (melanolipofuscin, ML). New
concepts of human RPE cell biology make fulfilling the potential of fundus AF more possible than ever. Each
adult human perifoveal RPE cell has >1400 organelles that generate reflectivity for optical coherence
tomography (OCT). Half are LF or ML that also generate fundus AF (FAF) signal to blue-green exciting light.
Melanosomes (M) preferentially localize to apical processes and may contribute their own FAF signal. The
congruent topographies of FAF and photoreceptors has been confirmed and detailed, with low signal in the
fovea and strong signal at a ring of high rod density encircling fovea and optic nerve head. At this ring is also
an abundance of well-studied bisretinoid fluorophore A2E. By OCT, hyperreflective foci conferring high
progression risk include RPE anteriorly migrating into the retina. A far-reaching new finding from the previous
project period is that foveal RPE is dominated by ML, thus imparting a specific molecular signature to RPE at
this cone-rich site. Consistent with regional molecular differences in RPE, our imaging mass spectrometry
(IMS) studies revealed lipid signals specific to RPE in central macula. Unresolved questions are whether
multiple fluorophores localize to each organelle, what organelle emits FAF signal with near-infrared (NIR)
excitation, and what molecules are responsible for macular AF. We hypothesize that major fluorophores driving
macular FAF signal are bisretinoids localized to specific organelle subtypes, which in turn are regionally
distributed in accordance with the distribution of cones and rods. Drs. Curcio, Ach, and Schey, members of the
multidisciplinary Hyperspectral Retinal Autofluorescence Team (HYRAFT) with expertise in AMD pathology,
clinical imaging and microscopy, and analytic chemistry, respectively, propose studies in human donor eyes to
address these knowledge gaps. In RPE-choroid flat mounts and tissue cross-sections of aged normal (N=20)
and AMD (N=25) eyes subject to ex vivo OCT, Aim 1 will fortify a regional and morphologic basis of FAF
imaging using tissue cross-sections to use imaging mass spectrometry to identify lipid signals including
fluorophores. In these tissues Aim 2 will enumerate and determine emission spectra of LF, ML, and F in 3-
dimensions using high-resolution structured illumination microscopy and a NIR-sensitive camera. Aim 3 will
use discontinuous sucrose gradients to isolate RPE organelles in pooled maculas and peripheries (80 normal
eyes, 40 donors) to extract fluorophores, separate them with fluorescent thin layer chromatography, and
identify fluorophores using liquid chromatography – tandem mass spectrometry. Results will directly translate
to molecularly informed clinical FAF imaging by many technologies, in AMD and other retinal disorders.

Public health relevance
NARRATIVE Strong autofluorescence signal from the retinal pigment epithelium (RPE) has high potential for noninvasive, spatially and molecularly precise early detection, and longitudinal follow-up for AMD clinical trials. Using human donor eyes, we will use high-resolution microscopy and imaging mass spectrometry to localize RPE organelles emitting autofluorescence signal in regions rich in cone or rod photoreceptors, as well as areas in high-risk AMD pathology. With analytic chemistry we will identify the responsible molecules.